Trajectories of Maternal Needs and their Impact on Mother Infant Interactions

ABSTRACT
Mothers experience many needs in the initial 6 weeks postpartum.1–9 Recently, mothers in the US are
experiencing a rising incidence of postpartum hemorrhage, sepsis and preeclampsia,1,2 and reporting more
mental health problems, such as postpartum anxiety or depression, than in 1990s.6,10 Despite increasing
postpartum morbidity and mortality rates, mothers in the United States do not follow-up with a provider until 6
weeks postpartum.12 The timing of this postpartum visit has been debated by the American College of
Obstetrics and Gynecology (ACOG) with increasing evidence that the 6 weeks postpartum visit may be
insufficient.13,14 Current research falls short of describing the trajectory of needs between the time a mother is
discharged from the hospital to the routine follow-up visit at 6 weeks postpartum. The purpose of this
longitudinal mixed method study is to describe the needs of 60 mothers with healthy, infants >37 weeks
gestation at birth during the first 6 weeks postpartum and to explore how maternal needs affect mother-infant
interactions. Asynchronous digital diary data collection will occur through text messages and will allow mothers
to provide data at a time convenient to them and their infants. Data can be collected with limited participant
burden from 1 to 6 weeks postpartum. Additionally, one face-to-face interview at 6 weeks and 2 behavioral
observations at baseline and 6-weeks will allow the researcher to explore gaps using text message data
collection and explore the impact of maternal needs on mother-infant interactions. Using these techniques, this
study aims to 1) Describe the trajectory of maternal needs and resources across the first 6 weeks postpartum
by race/ethnicity, parity and education, and 2) Explore the characteristics of early mother-infant interactions
based on mothers with more or fewer needs.

Public health relevance
PROJECT NARRATIVE Mothers experience many types of needs (e.g., mood, feeding, sexuality, contraception, sleep and fatigue, physical recovery, medications) in the first 6 weeks after birth.1–9 This study will describe the trajectory of needs of 60 mothers with healthy, full term infants during the first 6 weeks after birth and explore how maternal needs affect mother-infant interactions. Findings from this study may help researchers and clinicians better address maternal and infant needs by understanding when mothers are experiencing each type of need after birth and how these needs impact mothers, infants and their relationship with each other.